Project 1: Integrated Transcriptomics of Severity, Immunotherapy, and endotypes in Peanut Allergy

SUMMARY - Project 1
Peanut allergy is a clinical and public health problem that affects 2.2% of children and 1.8% of adults in the
United States. Individuals with peanut allergy are at daily risk for potentially life-threatening hives, angioedema,
respiratory difficulty, cardiovascular compromise, gastrointestinal distress, and/or anaphylaxis following peanut
ingestion. Intake of equal amounts of peanut protein may cause anaphylaxis in one person but only minor
throat itching in another, despite similar allergy test profiles. Mechanisms underlying this variability in severity
have been elusive. Oral immunotherapy (OIT) enables desensitization for some individuals but leads to
variable gains in reaction threshold and is not effective for all. Project 1, “Integrated TRanscriptOmics of
SEverity, ImmunoTherapy, and EndoTypes in Peanut Allergy” (ROSETTA), will study well-phenotyped
peanut allergic children systematically undergoing double-blind, placebo-controlled oral food challenges
(DBPCFC) before and after OIT as part of this application's PATHWAYS Clinical Core. Children across all
levels of severity and threshold will be included. Based on threshold determined at baseline, each will receive
low-dose OIT with commercial product or higher dose OIT with peanut butter trialed during our previous
AADCRC. The central goal of ROSETTA is to rigorously address knowledge gaps about severity and
endotypes in peanut allergy and its treatment. Research by our group and others has demonstrated the
power of whole blood and single-cell transcriptomics to uncover new insights about peanut allergy. We will
leverage the rich phenotypic data and biosamples collected from peanut allergic children undergoing
DBPCFCs and personalized OIT within our PATHWAYS Clinical Core to achieve our aims. In Aim 1, we will
lead a single cell study of reaction severity in peanut allergy. We hypothesize that dynamic changes in
specific subpopulations in peripheral blood are associated with reaction severity. We will generate single cell
RNA sequence time series of children undergoing DBPCFC to characterize the dynamics and gene expression
of cellular subpopulations associated with reaction severity. In Aim 2, we will identify molecular networks
causally shaped by peanut immunotherapy. We hypothesize that key biological processes are altered by
OIT. We will find peripheral blood transcriptomic signatures associated with response to OIT and apply novel
systems biology approaches to elucidate molecular networks shaped by peanut OIT and key drivers of OIT
response. In Aim 3, we will discover endotypes of response to peanut immunotherapy. We hypothesize
that endotypes of response to peanut OIT can be found through integrated multi-modal analysis of data from
peanut allergic children undergoing OIT. We will apply endotyping frameworks we developed to data from
PATHWAYS participants to identify endotypes of peanut OIT response. To ensure rigor, we have included
steps to validate the results from all aims of this project. We expect that the findings from ROSETTA will exert
high impact on the mechanistic understanding and therapeutic approach to peanut allergy.